Novel Methods for Clinical Trials in Dementia and Cognitive Decline

Abstract:
We will conduct an open-label double-blind group assignment clinical trial testing serum “adipokine” proteins
as the mediators of the Federal Drug Administration (FDA)-approved medication donepezil (Aricept®)’s effect
on the latent dementia severity metric “δ”. Adipokines are inflammatory proteins released by adipose tissues
and recently associated with cognitive decline. Our intent is to demonstrate multiple potential improvements in
the conduct of any future dementia-related clinical trial. For example, the use of telephone assessment
minimizes recruitment and assessment costs and protects participants from potential SARS-cov-2 exposure.
The entire protocol could be administered by telephone, if necessary, in subjects unvaccinated against
SARS-cov-2. In prior work, we have established the latent variable “δ” (for dementia) as a dementia-specific
cognitive phenotype. We will use δ to equate study groups on their baseline dementia severity and set the
recruitment threshold to maximize the potential for reversions back across δ’s dementia conversion threshold
if treatment is effective. We will deploy a novel “Line of identity (LOI)” algorithm to further select cases most
likely to benefit from our intervention (an example of precision medicine). We will use a second latent
dementia severity metric (dTEL) as a comprehensive dementia-specific outcome. Finally, we will test a latent
adipokine biomarker construct as a mediator of donepezil’s effect on δ. That will potentially establish a novel
mechanism for acetylcholinesterase inhibition.

Public health relevance
Narrative: In prior work, we have established the latent variable “δ” (for dementia) as a dementia-specific cognitive phenotype. δ can improve dementia-related clinical trials. This project pilots several methodological advances: 1. The use of telephone assessment to minimize recruitment and assessment costs (and protect participants from potential SARS-cov-2 exposure). 2. The use of a latent dementia severity metric (dECog) to equate study groups on baseline dementia severity. 3. The use of a novel “Line of Identity (LOI)” algorithm to select cases most likely to benefit from intervention (an example of precision medicine). 4. The use of a latent dementia severity metric (dTEL) as a comprehensive dementia-specific outcome. 5. The use of a latent biomarker construct as a mediator, potentially establishing a novel mechanism to explain acetylcholine esterase inhibitor (AChEI) effects.